INSTRUMENTATION CORE

INSTRUMENTATION CORE
SUMMARY
The Instrumentation Module provides Center for Visual Science (CVS) faculty with the expertise
in electrical, mechanical, and computer engineering necessary to develop novel devices and
instruments. The Module is staffed by three engineers with highly complementary backgrounds
and skillsets. Together, they enable the design, development, and refinement of custom
electronics (both analog and digital) as well custom mechanical devices. The Instrumentation
Module serves as the point of reference for the development of new experimental capabilities,
assisting participating faculty members from the very conception of ideas to the installation of the
new instruments in their laboratories. Thus, the experience and specialized expertise of the
module’s staff are an important foundation of the CVS research effort, making the Instrumentation
Module essential for CVS to continue breaking new ground in vision research.